Advanced Research Institute in Mental Health and Aging

The overarching goal of the "Advanced Research Institute (ARI) in Mental Health and Aging” is to increase the
number of early-career faculty successfully transitioning to independent investigators conducting high impact
research in mental health and aging that advances all four strategic objectives of the NIMH Strategic Plan. The
population is aging rapidly – in terms of longevity, absolute numbers and relative to other ages -- both in the
US and in much of the world. These demographic changes offer both challenges and opportunities for new
generations of researchers to explicate the contribution of aging to mental illness and to reduce the personal
and societal burden of mental illness in older adults. The number of investigators focused on mental health
and aging is small relative the size of the scientific and public health challenges. ARI will provide early-career
faculty a mentored, educational program to foster their transition to: Aim 1 (Independent Investigators)
measured by obtaining NIH R01-level (or equivalent) funding and, secondarily, research funding through other
NIH mechanisms or federal grant programs, and Aim 2 (Scientific Leaders) as evidenced by research
mentoring, retention as active researchers, publications, academic promotion, participation in team science,
and scientific service (e.g., NIH Study sections. The ARI national Mentoring Network is a multi-disciplinary
team of senior and mid-career scientists with complementary skills which span the translational spectrum of
brain, interventions and implementation science. The ARI Educational Program supports 16 early-career
faculty (called Scholars) annually with each Scholar’s participating for two years. Key elements include:
sustained mentoring focused on grant-writing and career development, consultation with biostatisticians, and
professional development. The program includes an annual in-person Spring Retreat, structured long-distance
follow-up, and web-based career development seminars. New features to this program include 1. enhancing
the educational program with formal mentor training and resources for both Mentors and Scholars; and 2.
building biostatistical consultation support through a mentored fellows program. Public Health Impact: The
unmet mental health needs of older adults is a significant public health problem that affects not only those who
suffer from mental disorders but their families, care providers, communities, and institutions that deliver and
pay for care. The research challenge includes reducing the burden of mental illness in older adults while also
explicating how the process of aging contributes to the risk, expression, and outcomes of mental illness
throughout the adult life span. The capacity of research to meet this challenge rests largely on ongoing
enrichment of the field with new independent investigators from across the translational spectrum with state-of-
the-art training and innovative ideas. ARI will build this capacity by developing the next generation of
independent investigators and scientific leaders conducting high impact research in mental health and aging.

Public health relevance
The "Advanced Research Institute (ARI) in Mental Health and Aging” is an educational program for early- career faculty designed to help them successfully transition to independent investigators. Key elements of the program include a large network of mentors, an annual Spring Retreat, structured long-distance follow-up.